USC-UCLA Drug-Induced Liver Injury (DILI) Clinical Center.

Project Summary/Abstract
The USC-UCLA Drug-Induced Liver Injury Clinical Center (CC) proposal in response to RFA-DK-17-509
“Limited Competition for the Continuation of the Drug Induced Liver Injury Network (DILIN) Clinical Centers”
hopes to continue to participate with the other CCs to advance the scientific knowledge and clinical evaluation
of DILI. Our proposal will continue to combine the only two medical schools in Los Angeles County allowing us
to be able to uniquely capture and enroll DILI cases into the Networks database supervised by the Data
Coordinating Center (DCC). The 10.1 M residents of Los Angeles County (2016) are an unmatched resource
composed of the most ethnically diverse population in the United States. Our proposal continues to utilize the
expertise and talents from Keck School of Medicine of USC and David Geffen School of Medicine at UCLA.
The enrollment of a large number of bona fide and ill patients with close follow up has demonstrated our CC’s
ability to capture DILIN cases in this diverse populations with little overlap in etiology for DILI other than for
HDS in our respective patient populations. The Specific Aims for the continuation of the USC-UCLA DILI CC
are to: 1) Continued enrollment of high quality bona fide DILIN case from under represented and Pediatric
populations with emphasis on increasing enrollment of acute cases; 2) Development of a treatment trial for
cholestatic liver injury; 3) Development of a treatment trial for acute hepatocellular Injury; and 4) Continued
support of the DILIN’s effort to develop causality assessment instruments and development of a pilot project for
a pharmacovigilance protocol for adverse liver injury due to medication or HDS.

Public health relevance
Project Narrative Prescription and non-prescription medications, which include vitamins, herbal preparations, or, non-traditional forms of medicines, can very rarely cause significant liver injury. Because these events are so rare, the NIH has established a network of investigators to identify these rare causes of liver injury so that a shared database can be used for future studies. The USC-UCLA Drug-Induced Liver Injury Clinical Center desires to continue to work with this established network to better understand causes of liver injury due to these agents.